Biological aging in early life: exploring developmental and environmental predictors of telomere length and impacts on subclinical atherosclerosis development

Abstract
Telomere length (TL), a marker of biological aging located at the ends of chromosomes, is longest at birth
and shortens over time. TL in early life is crucial for determining future TL and that TL dynamics during early
developmental stages are complex. However, early-life predictors of TL remain poorly understood, as is our
understanding of the rate of changes in TL during the first two decades of life and how this biological aging
process affect susceptibility to diseases in later life. Shorter TL in adults has been associated with increased
atherosclerotic morbidity and mortality, but the role of early-life TL dynamics in the development of subclinical
atherosclerosis remains unclear. The overall objective of this study is to understand how key growth and
environmental factors shape early-life TL and to determine the impact of TL and its changes from birth to young
adulthood on subclinical atherosclerosis development. Utilizing data from the Southern California Children's
Health Study, a longitudinal cohort, we will measure TL from stored biospecimens collected at birth (n = 1,297),
age 8 (n = 1,297), and age 24 (n = 400). This project will efficiently leverage a wealth of existing resources
including growth data from birth records and annual measurements, ambient and traffic-related air pollution
exposure based on lifelong residential history and environmental monitoring data, and subclinical
atherosclerosis indicators using carotid ultrasound measures—including carotid intima-media thickness,
vascular stiffness, and lipid deposition—collected at ages 11 and 24 years. Specifically, we will determine the
extent to which TL and its change from birth to adulthood are affected by growth (Aim 1) and exposure to air
pollution (Aim 2). Our working hypothesis is that higher birth weight, higher BMI growth rate across early life
course, and early obesity (for Aim 1), as well as lifetime air pollution exposures (for Aim 2), particularly during
some sensitive windows (e.g., early childhood, puberty) can shorten TL and accelerate its rate of change from
birth through childhood and young adulthood. We will also evaluate the impact of TL and its rate of change
from birth to adulthood on subclinical measures of atherosclerosis development from ages 10 to 24 (Aim 3).
Our working hypothesis is that shorter TL and faster rate of TL shortening from birth to young adulthood are
associated with higher attained subclinical atherosclerotic indicators at ages 10 and 24 and higher rate of
change in these measures from age 10 to 24. This project is poised to provide comprehensive insights into
how early-life TL is shaped by growth and environmental factors, and how it can impact the progression of
subclinical atherosclerosis. Our findings will inform how early changes in biological aging markers may respond
to growth and environmental stressors and may subsequently influence the development of aging-related
diseases, ultimately offering innovative treatment and prevention strategies to transform public health
approaches, targeting the early-life origins of disease with the aim of extending healthy lifespan.

Public health relevance
Project Narrative This study will examine how early-life factors like growth patterns and exposure to air pollution affect telomere length—a marker of biological aging—from birth to young adulthood. We will in turn further examine how telomere length can impact measures of subclinical atherosclerosis—the underlying cause of heart attack and stroke. These findings will improve our understanding of how biological age and related disease develop from early life, thus leading to new strategies to enhance long-term health starting from childhood, ultimately helping to lengthen life and reduce illness and disability.